Metadoxine as a novel pharmacotherapy for older adults with alcohol use disorder

PROJECT SUMMARY
This K99/R00 proposal examines a novel pharmacotherapy for alcohol use disorder (AUD) in older adults (aged
≥65). As the population is aging at an unprecedented rate and alcohol is the most commonly used drug among
older adults, AUD in the older adult population is becoming an increasing area of importance in public health and
clinical research. Chronic alcohol consumption leads to accelerated aging and exacerbation of age-related
sequelae, including chronic inflammation and cognitive decline. Therefore, identifying a safe and effective
treatment option for older adults with AUD is critical. As older adults tend to have co-morbid health conditions
which necessitate being prescribed multiple medications, adding a medication with few drug-drug interactions is
paramount. Metadoxine is a medication approved in Europe for the treatment of acute alcohol intoxication as it
is able to induce urinary excretion of ethanol from the body. Metadoxine is formed by the salification of pyridoxal
(vitamin B6) and pyrrolidone carboxylic acid and has an excellent safety profile. Moreover, metadoxine has been
shown to be associated with reduced alcohol craving, improvement on cognitive tests, and decreased
inflammation. Preliminary data also suggest that metadoxine may reduce alcohol consumption. However, no
studies have evaluated metadoxine safety or efficacy in older adults nor used a cue reactivity paradigm to assess
craving. During the K99 phase, we propose a within-subjects, crossover, double-blind, placebo-controlled human
laboratory safety and tolerability study in older adults (aged ≥65) with AUD. For the R00, we propose a pilot
double-blind, between-subjects, placebo-controlled randomized controlled trial (RCT) in older adults (aged ≥ 65)
with AUD. For the pilot RCT we will assess acceptability and feasibility of metadoxine for older adults, evaluate
the effect on alcohol craving using an established cue reactivity paradigm, and assess the effect on coginitive
function relative to placebo. Additionally, we will obtain data on the efficacy of metadoxine for reducing alcohol
consumption and inflammation. The research plan is complemented by an exceptional mentorship team and
training plan at the Center for Alcohol and Addiction Studies, School of Public Health, Brown University. The
application builds on the applicant’s extensive background in aging and neuroscience and clinical alcohol
research by proposing new, focused mentorship in specific methods related to human laboratory studies, clinical
trials, gerontological research, and biostatistics with clinical data. The combined research and training plans will
prepare the applicant for a successful independent career in clinical alcohol research focused on identifying
novel treatments for older adults. This research is aligned with NIAAA’s strategic goals to develop and improve
treatments for AUD and alcohol-related consequences and to enhance the public health impact of NIAAA-
supported research. This research is urgently needed as the older adult population continues to grow
exponentially and prevalence of AUD continues to increase.

Public health relevance
PROJECT NARRATIVE The older adult population (aged 65 and older) is the fastest growing segment of the U.S. population and drinking is also increasing in older adults. Aging leads to a number of health issues including inflammation and decreased cognitive function, which are made worse by alcohol drinking. This project seeks to test a potential medication for treating alcohol use disorder in older adults.